Circadian timekeeping in hamster mutants

PROJECT ABSTRACT
Aberrant light exposure disrupts daily rhythms in humans and is linked to many diseases. This is a serious
public health concern because light at night impacts up to 80% of Americans. Further, polymorphisms in
circadian genes alter sleep and responses to light, which produces high personal and societal burdens.
Despite many gains in the field, a major gap remains in understanding how changes in molecular clock
function translate into phenotype and pathology. One obstacle is the common use of mouse models that lack
systemic cues present in humans and other mammals (e.g., melatonin). The Syrian hamster is a melatonin-
competent rodent with an impressive repertoire of circadian and photoperiodic responses to light. Having
developed the first circadian reporter in a hamster model, here we will investigate circadian timekeeping at the
central and systems-level in this informative species. Further, we will leverage well-characterized mutations
present in the hamster that affect circadian clock function, photoentrainment, and physiology. This work will
lay the essential foundations to use this animal model to gain a more holistic understanding circadian and
photoperiodic processes that impact health.

Public health relevance
PROJECT NARRATIVE The suprachiasmatic nucleus (SCN) regulates the activity of nearly every system in the brain and body. Disruption of circadian rhythms has been linked to a growing number of human diseases, including increased risk of cancer, cardiovascular disease, obesity, neural degeneration, impaired cognition, and severe immunodeficiency. By investigating how mutations in circadian clock genes affect SCN function and its coordination of circadian clock tissues throughout the body, these studies will generate novel insights into how circadian organization of physiology and behavior is maintained under normal conditions and degraded under pathological states. These insights will comprise the basic foundations upon which novel treatments for alleviating these health risks can be developed.